SPF 4 Rhesus Macaque Breeding Colony for AIDS Research

PROJECT SUMMARY, Overall
A safe, effective vaccine continues to be the best hope for controlling the Human Immunodeficiency Virus
(HIV) pandemic. Due to similarities between the Indian-origin rhesus macaque (Macaca mulatta) and human
immune systems, vaccine development, as well as other approaches for controlling AIDS, are heavily
dependent upon the SIV and SHIV macaque models. There is a continuing need for Indian-origin rhesus
macaques to support this work. Domestic breeding programs that are designed to efficiently produce well
characterized Indian-origin rhesus macaques are necessary to ensure the supply of biomedical research
subjects required for AIDS vaccine development and treatments, and pathogenesis studies. The purpose of
this proposal is to provide support for the genetically characterized, specific pathogen free, Indian-origin rhesus
macaque AIDS Research Colony resource that was established in 2001 at the Oregon National Primate
Research Center.

Public health relevance
PROJECT NARRATIVE The specific aims in this proposal are designed to continue our current efforts to maintain a genetically diverse MHC-defined SPF Indian-origin rhesus macaque colony supporting AIDS/HIV-related research focused on the use of opportunistic viral agents as vaccine vectors, and other approaches to AIDS prevention and treatment.